The oral microbiome as a window into the pathobiology of multiple sclerosis, leading to new ideas for personalized microbial therapies

Abstract
Multiple Sclerosis (MS) affects roughly 2.3 million people worldwide, with Relapsing-Remitting Multiple
Sclerosis (RRMS) making up 85% of all MS cases. Although the precise pathobiology of RRMS is not well
understood, it is linked to both genetic and environmental factors with an emerging important environmental
factor being the microbiome. Recent evidence has shown that the gut microbiota of MS patients differs from
that of healthy individuals, suggesting it likely plays a role in pathobiology. However, the importance of the oral
microbiome, which is the second most diverse microbiome (first being the gut), as a potential environmental
factor is poorly understood. Prior research on the oral microbiome has shown that it can affect not only our oral
health, but our systemic health. In fact, other neurodegenerative and autoimmune diseases have been linked
with the oral microbiome dysbiosis including Alzheimer’s, Atherosclerosis, and rheumatoid arthritis. Thus, the
investigation of the oral microbiome as an environmental factor in the pathobiology of MS is warranted
and this proposal will address this gap in knowledge. To test this hypothesis, we will analyze oral
biospecimens from 50 patients with RRMS and 50 healthy controls (HC). This cross-sectional comparison will
look at the differences and similarities in microbial composition and its associated function between the two
groups. Additionally, as the metabolome impacts host health and the microbiome can influence the host
metabolome, we will utilize an untargeted metabolomics approach to determine whether MS and HC oral
metabolites differ. Lastly, we will correlate the microbes and metabolites to identify the relationships between
the oral microbiome and the host metabolites as well as utilize machine learning to identify the most significant
features associated with the pathobiology of MS. Overall, this study will help in identifying specific oral
microbes, microbial functional pathways, and host metabolite pathways that may be used as potential
diagnostic biomarkers as well as therapeutic agents for patients with RRMS.

Public health relevance
Project Narrative Multiple Sclerosis (MS) affects nearly 2.3 million people worldwide, yet the specific causes of MS have not been identified, and thus, treatment options are limited. As the oral microbiome and metabolome have provided key insights into the understanding of other neurodegenerative and autoimmune disease, but similar research is lacking for MS, this project will study these aspects in patients with Relapsing-Remitting Multiple Sclerosis (which makes up 85% of all MS cases). These findings will bring us a better understanding of MS along with the potential to develop individualized microbial based therapies in the future.